Investigating Novel Functions for NIK/MAP3K14 in High-Grade Glioma

PROJECT SUMMARY
Cancer cells are able to adapt to grow uncontrollably and invasively in environments with limited availability
of nutrients — most notably, glucose and oxygen. Indeed, the aggressive migration and invasion of high-
grade gliomas, including glioblastoma multiforme (GBM), into healthy brain tissue are major factors
contributing to the therapy resistance and poor prognosis of this malignancy. While many cancer cells
preferentially utilize glycolysis to support growth, GBM cells have been shown to rely on both glycolysis and
mitochondrial metabolism for glucose energy utilization. Mitochondrial dynamics, or the balance between
mitochondrial fission and fusion, is a central mechanism for bioenergetic adaptations to cellular stresses
such as nutrient deprvation. Therefore, targeting de-regulated mitochondrial function is a highly attractive
therapeutic strategy for GBM. Recent findings have established key roles for NF-κB-inducing kinase
(NIK/MAP3K14) in regulating mitochondrial dynamics and subcellular trafficking to promote the
invasiveness and pathogenesis of GBM cells. Moreover, preliminary data demonstrate that mitochondrial
NIK enhances the resistance of GBM cells to nutrient/glucose starvation through regulation of mitochondrial
metabolism. Moreover, the mitochondrial actions of NIK are independent of its regulation of NF-κB activity.
However, the molecular mechanisms by which NIK coordinates regulation of mitochondrial function and
metabolic reprogramming in GBM cells are currently not known. This proposal tests the hypothesis that NIK
is induced by, and is an important regulator of, mitochondrial dynamics, cancer cell metabolism and
infiltrative growth in response to nutrient deprivation. The goals of the proposal are to functionally define
NIK-dependent regulatory networks and metabolic pathways that regulate cancer cell mitochondrial
functions and test the whether NIK inhibition will sensitize GBM cells to nutrient starvation and attenuate
tumor cell survival and pathogenesis. This proposal is anticipated to have an important positive impact
because understanding the molecular basis of NIK mitochondrial functions is likely to generate strong
justification for the development of novel, mechanism-based therapies for GBM that target mitochondrial
dysfunction, invasion, and de-regulated metabolism through NIK inhibition with the ultimate goal of
improving patient survival.
!

Public health relevance
PROJECT NARRATIVE Due to its aggressive invasiveness, high-grade gliomas (HGGs) have one of worst prognoses among all types of human cancers, and the efficacy of current therapies remains poor. Our project seeks to define how NF-kB-inducing kinase (NIK/MAP3K14) regulates mitochondrial dynamics and metabolism to enhance glioma cell invasion and pathogenesis in response to nutrient starvation conditions that are hallmarks of growing tumors. These studies will establish a framework for the design of new therapeutic strategies based on the ability of NIK inhibition to confer sensitivity of HGGs, as well as other invasive cancers, to metabolic modulation. !